Off-the-shelf CAR-Engineered Macrophage Therapy for Alzheimer’s Disease

Project Summary
Alzheimer's disease (AD) affects 6.7 million Americans. Extracellular deposition of E-amyloid (AE) and
accumulation of hyperphosphorylated-tau inside neurons are two primary culprits of AD pathology and targets
for emerging AD therapies. Recent clinical trials of anti-AE monoclonal antibodies (mAbs) in AD patients showed
AE deposition can be reversed resulting in significant slowing of cognitive decline. Yet, anti-AE immunotherapy
comes with several shortcomings. These include need for recurring mAb infusions, staggering costs, and serious
side effects in the form of brain bleeds and/or edema, and contraindications disqualifying a large number of
patients. Chimeric antigen receptor (CAR) therapies have recently revolutionized several areas of oncology and
hold high promise for adaptation in other medical fields including neurodegeneration, where CAR-engineered
macrophages (Mĭs) can be used for targeted clearance of disease specific misfolded proteins and modulating
neuroinflammation. A key issue in CAR-based therapies are their high costs resulting from in vitro engineering
of patient-derived T cells or Mĭs and subsequent autologous implantation. This can be addressed using HLA-
compatible, “off-the-shelf” human induced pluripotent stem cells (hiPSCs) as a platform for expressing disease
specific CARs. This R61/R33 application proposes to develop a unique CAR-Mĭ therapy for AD based on “off-
the-shelf” hiPSCs, which will be genetically programmed for fast and robust transdifferentiation into self-
sustainable, macrophages/microglia (iMĭ) expressing CARs targeting AD specific proteins. Our CAR-iMĭs will
be engineered to withstand
CSF1R
inhibition
, which will be used to facilitate their brain homing. They also will
be
modified for attenuated inflammatory response and equipped with “kill switches” for therapy control. Our
preliminary work for this grant application includes identification of five novel anti-AE clones binding AE deposits
and effecting their clearance in APP/H3 mice by Fc-mediated microglia phagocytosis. We also have engineered
a doxycycline-inducible genetic circuit expressing SPI1 and CEBPĮ transcription factors allowing for robust trans-
differentiation of hiPSCs into iMĭ. Aims of the R61 phase are as follows: 1) to optimize iMĭ transdifferentiation
protocol and characterize resulting iMĭ cells; 2) to engineer CARAE using scFv sequences from our novel anti-
AE clones and express them in iMĭs; 3) to engineer an orthogonal CSF1 receptor, which will be constitutively
active and resilient to pharmacological inhibition; 4) to reprogram hiPSC HLA to “cloak” the cells against the
intact murine immune system permitting in vivo testing. Aims of the R33 phase will be as follows: 1) to produce
CARAE-iMĭs by combining all singular genetic elements tested in the R61 phase and characterize CARAE-iMĭ
biodistribution, brain homing and survival in vivo; 2) to test engagement and clearance of AE plaques by CARAE-
iMĭs in APP/H3 and APP/H4 mice; 3) to characterize the transcriptomic profile of CARAE-iMĭs in APP/H3 and
APP/H4 mice and explore effects of knocking-out genes, which are key to acquisition of
MGnD
phenotype and
propagating inflammatory response; 4) to engineer and test “kill switches” for on demand activity control.

Public health relevance
Project Narrative This R61/R33 proposal outlines development of a novel, cost-efficient, CAR Macrophage/Microglia therapy for Alzheimer's disease, which will lead to targeted clearance of disease specific proteins. It will carry a low- inflammatory signature and attenuate neuroinflammation, which inherently co-exists with Alzheimer pathology.